Coin2Dose: Behavioral economics to promote insulin BOLUS activity and improve HbA1c in teens

PROJECT SUMMARY
This R01 responds to PAS-20-160 (Small R01s for Clinical Trials Targeting Diseases within the Mission of
NIDDK). Our objective is to test the feasibility, acceptability, and initial efficacy of using behavioral economics
incentives (BEI) in a novel, semi-automated intervention to target daily insulin BOLUS scores in adolescents with
suboptimal insulin use. There is a critical need for efficacious and easy-to-implement interventions targeting self-
management behaviors in adolescents with type 1 diabetes (T1D). This is because national registry data suggest
that only between 15-28% of adolescents achieve their glycated hemoglobin (HbA1c) target, thereby placing the
majority of them at increased risk for serious acute and long-term complications. BEI interventions are efficacious
for promoting health behaviors including frequency of self-monitoring blood glucose (SMBG) in youth. Moreover,
there is evidence that BEI can be relatively easy to implement, especially when using Non-Contingent BEI. But
with the uptake of integrated insulin pump and continuous glucose monitor (CGM) systems and the new FDA
approval enabling youth to dose for insulin based solely on CGM, we believe the long-term value of targeting
SMBG alone in BEI interventions is limited and that daily insulin use is the next logical self-management target.
Building off of our prior work, the insulin BOLUS score offers a specific, measurable, and valid treatment target
for daily insulin use that is also more closely related to HbA1c than SMBG or Total insulin boluses per day. Thus
our Aims are: 1) examine the feasibility and acceptability of our semi-automated BEI intervention (called
Coin2Dose) targeting daily BOLUS scores in adolescents and 2) examine the preliminary efficacy of Coin2Dose
versus a standard care control (SC) group on youth daily BOLUS scores, HbA1c, and glucose time in range
(TIR). We also include an exploratory aim to examine the incremental impact of using Contingent versus Non-
Contingent BEI within our Coin2Dose intervention on youth’s BOLUS scores, HbA1c, and TIR. Coin2Dose will
deliver automated text messages to cue adolescents to bolus for insulin, plus BEI for daily BOLUS activity. To
enhance the scientific rigor of this R01, we will use the ORBIT Model for behavioral intervention development.
Consistent with this model, we will recruit 180 adolescents and a parent to participate in 1- a telehealth focus
group (ORBIT Phase 1a: Define; n= 20), 2- a formative pre-test (ORBIT Phase 1b: Refine; n=10), or 3- a pilot
randomized clinical trial (ORBIT Phase 2: RCT Pilot; n=150). Our RCT Pilot will randomize teens with suboptimal
insulin use (BOLUS score <2.5; ~70% of teens based on pilot data) to SC or 1 of 2 versions of Coin2Dose that
only differ based on our use of personalized (Contingent) v. non-personalized (Non-Contingent) BEI.
Adolescents will participate in 12-weeks of active treatment, plus a 12-week follow-up period. This small R01 is
Significant for its potential to yield: 1- preliminary data examining our new BEI intervention targeting daily BOLUS
scores, which may also improve youth HbA1c, 2- novel data exploring the incremental impact of Contingent v.
Non-Contingent BEI, which has implications for Coin2Dose as well as the broader uptake of BEI interventions.

Public health relevance
PROJECT NARRATIVE This study is relevant to public health because most adolescents with type 1 diabetes struggle to achieve optimal diabetes self-management and their target glycated hemoglobin level (HbA1c), thereby increasing their risk for serious acute and long-term complications. Behavioral economics incentives (BEI) can be effective in promoting adolescent self-management and relatively easy-to-implement in novel self-management interventions. Thus, if researchers achieve the aims of this project, the results will be data examining the initial feasibility, acceptability, and efficacy of a novel BEI intervention targeting daily insulin use in adolescents with type 1 diabetes which may also improve their HbA1c levels and be scalable for immediate clinic uptake and for use in future multicomponent adherence-focused interventions.